Genetic Engineering of Myeloid Cells to Treat Cancer

PROJECT SUMMARY/ABSTRACT
Background: Despite the success of T cell therapies in treating hematologic malignancies, solid tumors
remain a significant challenge due to their dense fibrotic stroma, immunosuppressive microenvironments, and
antigen heterogeneity. Current adaptive cell therapy approaches struggle to overcome these barriers,
highlighting the need for novel strategies. Myeloid cells, including macrophages and dendritic cells, possess
inherent abilities to infiltrate tumors, secrete cytokines, and cross-present antigens within the tumor
microenvironment, making them ideal candidates for therapeutic engineering. However, engineering these
cells is technically challenging, and tumors often co-opt myeloid cells to suppress adaptive immunity. We aim
to overcome these obstacles by applying advanced genetic engineering tools to reprogram myeloid cells,
enhancing their tumoricidal activities and resistance to polarization into immunosuppressive states. Toolbox:
We have developed a toolbox of new techniques that will allow us to overcome key engineering challenges in
human myeloid cells. Recognizing that nucleofection can lead to significant toxicity and dysfunction, we have
found that using enveloped delivery vehicles (EDVs) to deliver Cas9 preserves myeloid cell viability and
functionality. Additionally, through a collaboration with the Landau lab, we have shown that lentivirus
incorporating the Vpx system leads to highly efficient transduction of human myeloid cells. We have further
engineered these lentiviruses to express a mutant VSVG and scFvs targeting myeloid-specific surface
proteins, enabling selective transduction of specific myeloid compartments. Approach: 1) CRISPR Gene
Editing: These tools will enable us to perform CRISPR-based knockout and base editing screens in primary
human macrophages and dendritic cells to identify and modify key genes that regulate myeloid cell polarization
and effector functions. In addition, we will explore base editing of genes with known roles and mutations in
autoinflammatory diseases driven by overactive myeloid cells. 2) Synthetic Receptor (Innate-CAR) Library:
To complement these gene editing approaches, we will design and test a library of synthetic receptors, which
we call Innate-CARs, to enhance myeloid cell immunogenicity. These Innate-CARs will combine a tumor-
specific scFv with intracellular domains from a variety of diverse innate immune receptors and intracellular
proximal signaling molecules to optimize myeloid cell responses to tumor antigens. After we screen and
identify top-performing Innate-CARs and gene edits, we will use a variety of immunodeficient and
immunocompetent preclinical models to assess these enhancements in CAR-myeloid cell antitumor immunity.
3) In Vivo Engineering: Using our novel myeloid-targeting lentiviruses, we will evaluate the efficiency and
efficacy of in vivo manufactured Innate-CAR myeloid cells in tumor-bearing humanized mouse models.
Impact: By exploring the synthetic space of myeloid cell biology, we aim to push the boundaries of current
immunotherapy paradigms and pave the way for new, effective living medicines to treat refractory solid tumors.

Public health relevance
PROJECT NARRATIVE: Therapies derived from the adaptive immune system, such as T cells, have achieved remarkable success in treating liquid tumors, but solid tumors remain a significant challenge. This project will use innovative engineering strategies to harness the innate immune system, which naturally infiltrates tumors and can both directly kill tumor cells and activate T cells against cancer. By engineering key aspects of innate immune cells, we aim to create living medicines capable of effectively combating solid tumors.